NINR Intramural Research Training Programs

NINR training programs include the Methodologies Boot Camps (Pain; Fatigue and Sleep; Big Data in Symptoms Research; Precision Health: from Omics to Data Science; Precision Health: Smart Technologies, Smart Health, Artificial Intelligence), Summer Genetics Institute, pre- and postdoctoral fellowships, and other Institute-sponsored intramural research and training opportunities. 1. Symptom Methodologies Boot Camp. 2021 Artificial Intelligence The 2021 Boot Camp explores the impact that Artificial Intelligence (AI) has in the evolving healthcare environment to improve the care of all patients and families in an equitable way. The goal is to showcase how AI can improve outcomes and how to avoid unintended consequences that increase disparities. This year's focus pays particular attention to recognizing and reducing bias to promote equity. The boot camp has four objectives. First, it will describe the field of Artificial Intelligence (AI) and explore the role of AI to promote health, and to prevent illness. Secondly, it will discuss strategies to build partnerships and collaborations among clinicians and scientists. Thirdly, it will allow for a better understanding of the potential for AI to reduce disparities and describe pitfalls and identify strategies to detect and prevent bias in health-related algorithms. Lastly, it will allow participants to analyze prevention, clinical and translational AI applications to enhance quality of programs, policies and care to reduce health disparities and increase health equity. The event will be held entirely online and has generated great interest from across the country and internationally. Nearly 1000 people registered to attend virtually. The boot camp will be broadcast using two virtual formats to accommodate a large number of participants and to encourage a robust and interactive session. It will be held in three sessions on 9/13/21, 9/20/21, and 9/27/21 from 1:00-3:00 pm ET. Each session will focus on a theme (Session 1 Innovations and Improvements in Health Outcomes, Session 2 Clinical Applications, Session 3 Bias is Algorithms). For the first half of each session two speakers will discuss their research, and the second half is a panel Q&A to allow for robust discussion with the online participants. The entire event is available for on-demand viewing on the NINR YouTube channel. https://www.ninr.nih.gov/newsandinformation/events/bootcamp2021#agenda 2. Summer Genetics Institute (SGI) Program The 2021 SGI program was canceled to limit the spread of the novel coronavirus. 3. Graduate Partnership Program (GPP) The NINR GPP is part of the NIH intramural Graduate Partnership Program and was begun as a 3-year pilot program in the fall of 2003. The first NINR GPP fellow was accepted in the spring of 2004. In total for FY 2021, our program supported 1 graduate student from University of Missouri at St. Louis. 4. Postbaccalaureate IRTA fellow trainees in the DIR of NINR Five new postbaccalaureate fellows were accepted this past year. Of those who have completed their training, 30% entered medical school, 30% entered PhD programs, 10% entered a Masters program, and 30% entered the professional workforce. 5. Postdoctoral trainees in the DIR of NINR Several postdoctoral fellows have completed their training. Outcomes are categorized by sector, job type, and job specifics (Xu et. al. (2018) Nat Biotech 36:197-202). Sector: 60% have entered the government sector and 40% the academic sector. Job type: 35% entered the professional workforce, 35% seek additional training, 20% entered tenure-track/tenure-eligible positions, and 10% entered non-tenure track positions. Job specifics: 45% enter clinical research positions, 30% seek additional postdoctoral training, 20% enter science administration/grants management, and 5% primarily teach. 6. NINR Summer Internship Program The 2021 Summer Internship Program was held entirely online. Five undergraduate students with majors ranging from computer science to biology to neuroscience participated in the virtual internship. Three students presented their results (2 posters and 1 three-minute talk) during the Summer Presentation Program on August 4 and 5.